Phagocytic Removal of Apoptotic Cells

DESCRIPTION (provided by applicant): During animal development and adulthood, cells undergoing apoptosis, a cell death process essential for animal development and homeostasis, are rapidly internalized by other cells via phagocytosis (engulfment) and degraded inside engulfing cells. The removal of apoptotic cells provides a safe means for eliminating unwanted and dangerous cells from the body. Furthermore, it prevents tissue injury, inflammatory responses, and auto-immune responses that could be induced by the content of dead cells. The study of apoptotic-cell removal has also inspired the development of novel cancer treatment strategies. My long-term objective is to understand the molecular mechanism that controls the recognition, engulfment, and degradation of apoptotic cells, using the nematode Caenorhabditis elegans as a model organism. We believe that what is learnt from C. elegans will be translated to humans. These project studies mechanisms that drive the degradation of apoptotic cells, which are internalized into host cells, confined in a vacuolar structure called phagosome. Phagosomes undergo a maturation process through a series of membrane trafficking events and the end result is the degradation of cargos in the lumen. Our studies will reveal the temporal regulation mechanisms of the production (Aim 1) and turnover (Aim 2) of phosphatidylinositol 3-phosphate (PI3P), a lipid second messenger that plays an essential role in initiating phagosome maturation, on phagosomes, and how PI3P triggers the maturation process (Aims 3). Our study of the PI3P signaling mechanisms will shed light not only on the degradation of apoptotic cells, but also broadly, on the molecular mechanisms behind other PI3P-mediated membrane trafficking events, including endocytic trafficking and autophagy. PUBLIC HEALTH RELEVANCE: This project studies how apoptotic cells (cells that commit suicide) generated in animal bodies are engulfed and digested by other cells, a process that protects humans from the harmful inflammatory and auto-immune responses that apoptotic cells would induce if they are left in the body. Understanding the mechanisms controlling this process will have important therapeutic implications, in fighting chronic inflammatory and auto- immune diseases, and in developing new strategies to remove cancer cells through engulfment and digestion.

Public health relevance
This project studies how apoptotic cells (cells that commit suicide) generated in animal bodies are engulfed and digested by other cells, a process that protects humans from the harmful inflammatory and auto-immune responses that apoptotic cells would induce if they are left in the body. Understanding the mechanisms controlling this process will have important therapeutic implications, in fighting chronic inflammatory and auto- immune diseases, and in developing new strategies to remove cancer cells through engulfment and digestion.